Rapid disease progression and viral reservoir formation in SIV-infected infant macaques

Despite significant reductions in mother-to-child HIV transmission (MTCT), HIV infection during breastfeeding
still occurs at unacceptably high rates, contributing to 150,000 new infections annually. Children are more
susceptible to AIDS-related illnesses than adults, with those under two years of age being more likely to succumb
to rapid disease progression than any other age group. Rapid progression in infants is characterized by immune
dysfunction that can include CD4 T cell depletion, B cell dysfunction and hypo-gammaglobulinemia (low plasma
levels of IgM/IgG). To investigate different rates of disease progression in infants, SIV-infected (SIV+) infant
rhesus macaques have proven to be a valuable model system, recapitulating several aspects of pediatric HIV
infection. Using this model, the Sodora laboratory identified a rapid progressor (RP) phenotype encompassing
high SIV plasma viremia and low or undetectable levels of SIV-specific antibodies. Additional analyses revealed
that RP infant macaques exhibit elevated and sustained type-1 Interferon (IFN-1) levels following the acute stage
of the infection, IFN-induced protein expression within B cell follicles (BCF), and that these changes were
associated with germinal center dysfunction within lymphoid tissues. These differences raise important questions
about the mechanism by which sustained IFN-1 signaling potentially contributes to rapid HIV/SIV disease
progression, as well as the relationship between progression rate and response to combination antiretroviral
therapy (cART), immune recovery following treatment, and establishment and maintenance of the latent viral
reservoir. Previous studies from Dr. Chahroudi’s laboratory (proposal co-investigator) revealed differences in the
latent SIV reservoir in infant compared to adult macaques, including a bias toward naïve CD4 T cells in harboring
the majority of latently infected cells in infants. These findings lead to our central hypotheses: 1. Rapid
progression in SIV+ infant macaques results from an elevated and prolonged type-1 IFN response that inhibits
formation of effective germinal centers in lymph nodes as well as an insufficient anti-SIV humoral immune
response. 2. Rapid progression in infants results in delayed immune recovery and a larger latent reservoir during
administration of combination antiretroviral therapy. Aim 1 will assess the ability of transiently administered IFN-
1 receptor antagonist, during the post-acute infection period to influence disease progression and immune
outcome in infant macaques. Aims 2 and 3 will evaluate the effectiveness of antiretroviral therapy on immune
recovery and latent viral reservoirs in both the RP and typically progressing infant macaques. Over the last 20
years, the Sodora laboratory has investigated immune factors that modulate SIV oral transmission and disease
progression in the rhesus macaque model, and the experiments outlined here expand upon these previous
studies. Undertaking experiments outlined in this proposal has the potential to identify therapeutic targets for
HIV+ infants with distinct disease trajectories and will provide insights into immune therapeutic approaches that
to aid in immune recovery and reservoir reduction.

Public health relevance
HIV infection results in rapid disease progression and death in infants more than any other age group. This proposal will assess the role of sustained type-1 interferon responses on the ability to mount humoral immune responses as well as the relationship between rapid disease progression and the latent viral reservoir. Our long-term goal is to identify therapeutic targets in HIV+ infants that exhibit rapid or typical disease trajectories to optimize antiretroviral drug administration and improve health outcomes.